PHASE I STUDY OF TAXOL FOR PATIENTS WITH PRIMARY OR METASTATIC LIVER TUMORS

To define the maximum tolerated dose of taxol that can be administered to patients with various degrees of hepatic dysfunction, and to define the toxicities of the drug.